Path C Vermont Agency of Agriculture, Food & Markets Produce Program Development

Project Summary/Abstract
Project Title: Vermont Agency of Agriculture, Food & Markets Produce Program Development -
PATH C
The Vermont Agency of Agriculture, Food and Markets (VAAFM) will continue development of
the Vermont Produce Program for the purpose of furthering implementation of the Food Safety
Modernization Act (FSMA) Produce Safety Rule standards for the safe growing, harvesting,
packing, and holding of fruits and vegetables grown for human consumption in our jurisdiction.
The project is a continuation of work begun under a previous five-year cooperative agreement
program (CAP) partnership with FDA to establish a produce safety regulatory program in our
jurisdiction.
The Produce Program’s overall purpose is to enhance produce safety and protect public health
by providing education, outreach, and technical assistance to all Vermont produce farms with
produce sales and by achieving and sustaining high rates of compliance with the Produce
Safety Rule among farms covered by the Rule. The Program’s Project Plan identifies key
objectives, timelines, and responsibilities for achieving these goals. The Vermont Produce
Program has a proven track record of achieving program targets and serving as a collaborative
partner with FDA, the National Association of State Departments of Agriculture (NASDA), the
Association of Food & Drug Officials (AFDO), Extension, and industry groups to enhance
produce safety and national consistency.
During the initial five-year CAP, the Program developed the foundational resources, systems,
staff, jurisdictional authority, and protocols to implement and continue a successful program.
VAAFM has adopted FDA’s Produce Safety Rule (21 CFR Part 112) in its entirety and conducts
inspections, compliance, and enforcement activities under state authority provided by 6 V.S.A.
Chapter 66: Produce Inspection (https://legislature.vermont.gov/statutes/chapter/06/066) and 6
V.S.A. § 21 (https://legislature.vermont.gov/statutes/section/06/001/00021).

Public health relevance
Project Narrative Project Title: Vermont Agency of Agriculture, Food & Markets Produce Program Development - PATH C This project supports the Vermont Produce Program's mission to enhance produce safety and protect public health by providing education, outreach, and technical assistance to all Vermont produce farms with produce sales and by achieving and sustaining high rates of compliance with FDA’s Produce Safety Rule among farms covered by the Rule. The goals and objectives of this project build upon the Produce Program’s initial five-year cooperative agreement program (CAP) partnership with FDA in implementing a produce safety regulatory program with a focus on quality and national consistency. The Vermont Agency of Agriculture’s application is made under Path C, and funding is requested for Education and Inventory Band 6 and Regulatory Band 10.